FACSAria Fusion cell sorter for Flow Cytometry Shared Resource

Project Summary/Abstract
The mission of the University of Texas Health Science Center at San Antonio Flow Cytometry Shared Resource
(FCSR) is to deliver high-throughput, multi-dimensional analysis and cell sorting using state-of-the-art equipment
for UT Health San Antonio investigators and others in the San Antonio area. The FCSR occupies over 800 sq.
ft. of laboratory space and is conveniently accessible in the center of campus. The FCSR accomplishes its
mission by allowing access to quality-controlled, highly specialized technology, education and technical
assistance in a cost-effective manner. All sorting demands for the entire campus are accomplished on two BD
instruments, one of which is in an individual PI laboratory and unavailable to institutional users. The one sorter
in the FCSR is heavily utilized and exceeds over 1500 hours of annual use, even though the maximum practical
capacity is approximately 1300 hours. This overutilization of the current sorter coupled with the increasing
demand and increasing downtime of this 17-year-old instrument due to its unreliability, leads to loss of valuable
samples and scheduling wait times of 2-3 weeks. In addition, a number of our users are sorting unique and highly
valued samples from human patients that become available on short notice and are in limited quantity.
Accommodating these users has become increasingly difficult due to the long wait times for sorter time and the
frequent downtime for the current sorter. Additionally, the performance and capabilities of the current sorter are
not sufficient to meet the increasing demand for higher parameter cell sorting. With the purchase of a 5-laser 40-
parameter Cytek Aurora full spectrum cell analyzer in June of 2019, many of our users have transitioned or are
in the process of transitioning to more complex >15-parameter analyses. The current BD FACSAria IIIu lacks
the ability to translate these panels into cell sorting for further downstream assays, thus limiting the research of
many of our most frequent users. This proposal is for purchase of a BD FACSAria Fusion cell sorter equipped
with five lasers (355, 405, 488, 561, and 637nm) capable of analyzing up to 18 different colors plus Forward and
Side Scatter. The instrument will provide desperately needed additional sorting capacity for the FCSR and will
also provide the capability for high parameter cell sorting and better detection and sorting of rare cell populations.
We are also requesting the optional integrated Baker Class II Type A2 biosafety hood and integrated Aerosol
Management System to accommodate sorting at BSL-2 containment.

Public health relevance
Project Narrative This application seeks funds to place a FACSAria Fusion cell sorting flow cytometer within the Flow Cytometry Shared Resource facility at UT Health San Antonio. Over the past 5 years, we have observed a 63% increase in the number of hours of cell sorting (12.5%/year) and now have reached maximum capacity. The proposed FACSAria Fusion cell sorter will replace our 17-year-old FACSAria III cell sorter and provide more reliable, higher parameter sorting capability.